Clinical utility of extracellular RNA as marker of kidney disease progression

DESCRIPTION (provided by applicant): Chronic kidney disease (CKD) is responsible for premature death from cardiovascular disease, infections and cancer, considerable human suffering and social costs. A large proportion of CKD patients develop end stage renal disease and require dialysis or kidney transplantation. Identifying patients at risk for CKD progression may facilitate precision medicine and prevent attendant complications. Development of mechanistic biomarkers predictive of CKD progression may help develop new treatment(s). Non-coding RNA (ncRNA), specifically microRNA (miRNA) is increasingly recognized as biomolecules that affect multiple cellular processes via regulation of gene expression. It is known that tissue RNA expression conveys information on disease status. Recently, it has been recognized that extracellular RNA (exRNA) is protected from nucleases by their encompassing microvesicles, and therefore can be measured in biological fluids including urine, and convey pathophysiological knowledge. Our labs have extensive experience in high throughput analysis of RNA expression. We have developed a cDNA deep sequencing method to profile miRNA in multiple samples, in a cost-effective, transcriptome-wide and bias-reduced manner. By studying thousands of diverse human samples we have discovered and curated miRNA and other small RNA. Currently, we are developing a parallel method to screen for all ncRNA. We have also adapted quantitative reverse-transcription polymerase chain reaction (qRT-PCR) technology to allow non- invasive verification and validation in larger study cohorts of patients with native and transplant kidney disease. We propose to apply our methods to comprehensively profile miRNA and other ncRNA in urine specimens collected from CKD patients. We aim to identify exRNA in the urine that can predict progression of CKD and develop prognostic biomarkers. We propose a 2-stage protocol; a discovery stage applying deep sequencing for transcriptome-wide profiling and identification of candidate markers, and a validation phase applying RT- qPCR to characterize additional samples and qualify the discovered findings. To allow rapid implementation of our research plan we established collaborations with investigators conducting longitudinal cohort studies of CKD. Urine specimens, linked with rich demographic, clinical and kidney outcome data are available from studies of both adult and pediatric cohorts; both glomerular and non-glomerular diseases; in both native kidneys and kidney transplant recipients. This permits discovery of biomarkers capable of predicting progression across the spectrum of kidney diseases as mechanisms of CKD progression are to a largely independent of CKD etiology. Nonetheless, our studies are powered for subgroup-specific biomarker discovery. Our preliminary findings confirm feasibility to profile exRNA in biofluids, and to detect associations with clinical relevant outcomes. We predict that our findings will inform basic scientist on RNA dysregulation in kidney disease progression and provide clinical scientist biomarker candidates for clinical trials.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic kidney disease is responsible for enormous human suffering and decreased life expectancy. Identifying patients with greater risk of worsening function of the kidneys may improve their care. We propose to examine urine of patients with kidney disease for the presence of small RNA molecules. We will follow patients to determine whether our approach can identify patients at risk for worsening disease, and will develop a laboratory test that can be used in the clinical setting to manage patients with chronic kidney disease. __SpecificAimsTextDelimiter__ ! Specific Aims Chronic kidney disease (CKD) includes patients with different etiologies and outcomes. The Kidney Disease Outcomes Quality Initiative classification of disease severity by estimated glomerular filtration rate (eGFR) and albuminuria has led to recognition of CKD as an important public health problem. eGFR decline varies among individuals with similar kidney disease, suggesting distinct processes irrespective of disease etiology. Preventing accelerated eGFR decline will delay development of end-stage renal disease (ESRD) and decrease CKD-related morbidity and mortality. A systematic understanding of the mechanism that contributes to these costly outcomes and human suffering and the development of tools for early detection are essential. Interstitial accumulation of extracellular matrix, tubular atrophy and glomerulosclerosis are histologic hallmarks of progressive CKD and constitute the final common pathway for disease progression in native kidney diseases and in kidney allografts. As these findings are only appreciated on kidney biopsy, non-invasive predictors for eGFR decline that includes baseline eGFR, serum cystatin C and albuminuria are currently used. Development of novel non-invasive biomarkers predictive of future kidney failure would constitute a transformative innovation since none of the current biomarkers are informative until kidney structure and function are markedly abnormal. Extracellular RNAs, in particular microRNAs (miRNA) have been implicated as early biomarkers for diagnosis and prognosis of cancer and cardiovascular disease. We and others determined that tissue and urinary miRNA levels correlate with phenotypical outcomes in patients with different forms of kidney injury. Examination of non-coding RNA (ncRNA) other than miRNA has been recently suggested to convey clinically-valuable information, but techniques to profile ncRNA are lagging. We hypothesize that urine extracellular RNA profiles allow identification of patients at risk for accelerated loss of kidney function at early stages, when intervention is more likely to ameliorate outcomes. To test this hypothesis, we propose to identify an extracellular miRNA signature from urine that predicts future progressive loss of kidney function. In established cohorts of pediatric and adult patients with diseases of the native kidney and kidney allografts followed longitudinally, we will use a novel barcoded, massively parallel deep sequencing strategy established in Dr. Tuschl’s laboratory and will validate identified transcripts by quantitative PCR assays, examining both etiology-specific and etiology-independent markers. Secondly, we will adapt assays for profiling of other extracellular ncRNA and provide initial evaluation of their biomarker capacity to predict CKD progression. Our specific aims are: (1) Determine whether extracellular miRNA expression patterns in urine of individuals with native and transplant kidney diseases associate with kidney function and kidney function decline. To identify extracellular miRNAs that associate with kidney function and its decline, we will study miRNA profiles of urine specimens obtained in study cohorts of individuals with native kidney diseases and allograft recipients. We will profile urine miRNA using barcoded massively parallel sequencing, and correlate to kidney outcomes: eGFR decline, proteinuria, ESRD and death. (2) Determine whether extracellular ncRNA can be profiled in urine of patients with kidney disease and whether urine ncRNA profiles associate with renal damage and kidney function decline. We will adapt a method for massively parallel sequencing of ncRNA currently being developed in the Tuschl lab for tissue ncRNA profiling to urine-based analysis. We will study a subset of the patient samples used for miRNA profiling to screen for candidate markers of progressive kidney dysfunction. (3) Determine whether extracellular miRNA and ncRNA expression signatures in urine are clinically useful biomarkers of CKD progression. We will verify and validate by quantitative PCR assay, extracellular RNA molecules identified by deep sequencing as candidates to serve as biomarkers of CKD progression. We will qualify etiology-independent predictors of progressive dysfunction, independently and co-introduced with known risk markers. In addition, we will perform subgroup and between-group analyses to identify disease- specific markers. We anticipate the development of non-invasive tests to identify patients with kidney disease who are at risk for accelerated loss of kidney function or adverse outcomes and would benefit from specific interventions to slow progression and aggressive management of risk determinants. Furthermore, our findings will provide novel insights into candidate mechanisms of accelerated loss of kidney function in patients with kidney disease by identifying dysregulated miRNAs and ncRNAs.